Gas-free cerebrovascular reactivity (CVR) MRI in vascular cognitive impairment

Project Summary/Abstract
Vascular cognitive impairment (VCI) is the second leading cause of dementia after Alzheimer’s disease
(AD). However, while AD biomarkers are relatively well developed, biomarkers for VCI pathology in the brain
are more limited. Cerebrovascular reactivity (CVR), an index of cerebral vessel’s capacity to dilate in response
to stimulation, is a promising marker of the brain’s vascular function. Our overarching hypothesis is that CVR is
a plausible biomarker for the diagnosis of VCI, for which no other biomarkers are currently available.
Despite some promises, CVR is not commonly measured in clinical practice, primarily due to logistical
difficulties in applying a vascular “challenge” during imaging. Current CVR measurement requires a vascular
challenge during imaging, involving either the injection of pharmacological agent (e.g. acetazolamide) or
inhalation of CO2 gas. However, these strategies are not ideal in terms of both patient burden and costs, due
to the complexity of the procedure, requirement of special equipment, and possible side-effect of physiological
maneuver to induce vascular challenge. Therefore, development of a CVR technique that does not need an
explicit vascular challenge will broaden the clinical utility of CVR in the diagnosis of VCI and vascular dementia.
The central goal of this project is to develop a gas-free CVR MRI technique that can provide comparable
sensitivity to CO2-inhalation CVR yet maintains a high comfort level to the subjects. This new technique is
largely based on resting-state scan and exploits spontaneous fluctuations in the subject’s breathing pattern,
but also introduces intermittent modulations of their breathing rhythm to enhance fluctuations in their end-tidal
CO2 (EtCO2). This project is divided into three logical steps. First, we will develop the gas-free CVR technique
in healthy subjects, for BOLD and CBF readouts as well as their integration (in Aim 1). Second, since previous
work on gas-based CVR has suggested that a large portion (~2/3) of variations in CVR data can be attributed
to physiological noise, we will identify physiological mechanism(s) of normal variations in gas-free CVR and
then account/control for them in order to reduce variations (in Aim 2). We will focus on two of the most
important factors that affect vascular tone in daily life, CO2 and caffeine levels, but will also consider other
physiological factors. Finally, we will apply the gas-free CVR technique in patients with mild cognitive
impairment with and without vascular risk factors, and compare its diagnostic sensitivity to an established
dementia biomarker of CSF Aβ42 as a benchmark, in order to examine the utility of gas-free CVR as a
potential biomarker in vascular cognitive impairment and dementia (in Aim 3).
Impact: Once these specific aims are accomplished, clinically practical methods of CVR will have been
developed that will have important applications for the development of biomarkers (in conjunction with other
biomarkers) for the diagnosis and treatment monitoring of vascular cognitive impairment and dementia.

Public health relevance
Project Narrative The brain’s reserve for blood supply provides important information of the brain health, and can be a sensitive biomarker in vascular cognitive impairment. Current technologies require the injection of pharmacological agents or the inhalation of CO2-enriched gases, which increase patient burden and may not be widely applicable. This project will develop a novel technique for measuring vascular reserve that does not need an explicit vascular challenge.